Next generation metabolic imaging of the effect of exercise on mitochondrial function in Alzheimer's disease

Project Summary/Abstract
While heart disease remains as the leading cause of death in the United States, an estimated 6.7 million
Americans aged 65 and older are living with Alzheimer's disease (AD) in 2023 and over 11 million American
caregivers providing an estimated 18 billion hours of care valued at $339.5 billion. These astronomical
numbers continue increasing as the whole population is aging. Furthermore, women are more prevalent to AD
and have higher risk to cardiovascular disease at older age than men. Currently no cure of AD and very limited
treatment that may slowdown AD, the best alternative care is to adapt lifestyle changes as recommended by
Alzheimer's Association and CDC. Lack of exercise is one of the key lifestyle factors contributing to the risk of
AD. Reducing these modifiable risk factors could reduce AD prevalence. Autopsy studies show that as many
as 80% of individuals with AD also have cardiovascular disease. Exercise has been shown to have numerous
benefits in both cardiac and cognitive function, and may slowdown AD. However, more mechanistic studies are
needed to elucidate the effect of exercise on metabolic and vascular health of both the brain and heart in AD.
Growing evidence suggests a close link between cardiovascular dysfunction and the AD progression.
Cardiovascular risk factors are associated with an increased risk of developing AD. Cardiovascular health
influences cerebral blood flow (CBF), and impaired blood flow to the brain can contribute to neurodegenerative
processes, including AD. Reduced cardiac function can lead to decreased oxygen supply to various organs,
including the brain, resulting in mitochondrial dysfunction, impaired energy production, and increased oxidative
stress, which are also observed in AD. Echocardiography has been performed on 5xFAD and found a
significant reduction in cardiac ejection fraction compared to wild-type controls, but no report on cardiac
metabolism. There is a gap in our knowledge of the interplay between vascular and metabolic health of the
brain and heart in AD, how these key functions may be improved by routine exercise to slow down AD
progression, and any gender differences.
In this pilot study, we will evaluate the feasibility of two non-invasive and translatable imaging techniques in
5xFAD AD model that rapidly recapitulates major features of AD amyloid pathology, with a moderate exercise
remedy over time to monitor their metabolic and vascular functions of the brain and heart associated with
amyloid pathogenesis. We will also investigate whether female and male mice benefit from exercise equally.
The techniques and multi-modal imaging proposed in this grant will allow us to probe how MRI can yield
metabolic and vascular information that may enable better classification, end points and mechanistic
understanding of the effect of exercise on AD and gender differences. These studies have direct translatable
value for human AD imaging research.

Public health relevance
Project Narrative Growing evidence suggests a close link between cardiovascular dysfunction and progression of Alzheimer's disease (AD), and cardiovascular risk factors are associated with an increased risk of developing AD. There is a gap in our knowledge of the interplay between vascular and metabolic health of the brain and heart in AD, how those key functions may be improved by routine exercise to slow down AD progression, and any gender differences. In this pilot study, we will evaluate the feasibility of two advanced, non-invasive, and translatable imaging techniques in an AD model that rapidly recapitulates major features of AD amyloid pathology, with a moderate exercise remedy over time to monitor their metabolic and vascular functions in the brain and heart associated with amyloid pathogenesis, and gender differences.